STATISTICAL METHODS IN AIDS RESEARCH

DESCRIPTION (adapted from the Abstract): The aim of this application is to develop statistical methods to make appropriate and efficient use of the data collected in epidemiologic and clinical AIDS studies. Two projects involving markers of disease progression and their relationship to clinical endpoints will be performed. They both utilize flexible and data driven methods, enabling more complete conclusions to be made about disease markers and clinical endpoints. In the first project the Investigator and his associates will develop, test, and apply a very general and comprehensive model for analyzing jointly longitudinal marker data and failure time data. The model incorporates (i) a smooth function for the marker population average, (ii) a flexible stochastic process determining marker progression, (iii) a time-dependent proportional hazards model for the endpoint with non-parametrically specified baseline hazard function, (iv) measurement error in the marker, (v) additional covariates influencing both the progression of the marker and the hazard of the event, and (vi) the ability to handle unbalanced and unequally spaced observations. This model will allow a proper assessment of the importance of markers and of other covariates in clinical and epidemiological studies. The model will be fit using Markov Chain Monte Carlo methods. The second project is to develop methods that will enable randomized clinical trials to be completed more quickly. The researchers will develop, test, and apply methods that recover information from censored observations using time-dependent markers to make efficient inference about the clinical endpoint. Two approaches will be developed, both utilizing multiple imputation of future clinical events followed by analysis of the augmented data. The first is an extension of the joint model in the first project, to forecast and thus impute future events. The second approach is to apply censored data regression techniques which allow for missing values to impute multiply for each censored case the event time. Non-parametric adaptations will be developed. The methods in both projects will be evaluated and compared to other approaches on simulated, clinical trial and Multicenter AIDS Cohort Study (MACS) data. The methodology has wide applicability to both AIDS and non-AIDS studies.